CRCNS Research Proposal: Cortico-amygdalar substrates of adaptive learning

PROJECT DESCRIPTION
1. BACKGROUND AND SIGNIFICANCE
Learning from feedback in the real w'orld is limited by constant fluctuations in reward outcomes
associated with choosing certain options or actions. Some of these fluctuations are caused by
fundamental changes in the reward values of those options/actions that necessitate dramatic
adjustments to the current learning strategies, like in epiphany learning or one-shot learning [Chen &
Krajbich, 2017; Lee et al. 2015]. Other changes represent inherent stochasticity in an otherwise
stable environment and should be tolerated and ignored to maintain stable choice preferences. In
other words, learning in dynamic environments is bounded by a tradeoff between being adaptable
(i.e. respond quickly to changes in the environment) and being precise (i.e. update slowly after each
feedback to be more accurate), which we refer to as the adaptability-precision tradeoff [Farashahi et
al., 2017; Khorsand & Soltani, 2017]. Therefore, distinguishing meaningful changes in the
environment from natural fluctuations can greatly enhance adaptive learning, indicating that adaptive
learning depends on interactions between multiple brain areas.
To date, most computational models of learning under uncertainty are very high-level and/or
descriptive [Behrens et al., 2007; Costa et al., 2015; ligaya, 2016; Jang et al., 2015; Nassar et al.,
201 O; Payzan-LeNestour & Bossaerts, 2011] and therefore, do not provide specific testable
predictions. On the other hand, neural mechanisms of uncertainty monitoring for adaptive learning
have been predominantly investigated in humans, and in a few cases monkeys, both of which are
limited in terms of circuit-level manipulations. However, interactions between brain areas unfold on
short timescales and can be specific to certain cell types. These properties have severely limited the
ability of functional MRI [Logothetis, 2003] or MEG [Dale et al., 2000; Mostert et al., 2015] to reveal
the microcircuit mechanisms within brain regions and fine-grained contributions between brain
regions. To overcome these limitations and reveal neural mechanisms underlying adaptive
learning under uncertainty, we propose a combination of detailed computational modeling,
imaging of stable neuronal ensembles, and precise system-level manipulation of interactions
between multiple brain areas in rodents. The latter is possible in part due to powerful circuit-
dissection techniques in rodents that allow manipulations of genetically-tractable cell types and thus,
specific projections between brain regions. Combined with decoding of neuronal activity in cortex
and guided by mechanistic computational modeling, this approach enables us to investigate both
microcircuit and system-level mechanisms of adaptive learning under uncertainty.
We have recently proposed a mechanistic model for adaptive learning under uncertainty
[Farashahi et al., 2017]. This model, which we refer to as reward-dependent metaplasticity (ROMP)
model, provides a synaptic mechanism for how learning can be self-adjusted to reward statistics in
the environment. The model predicts as more time spent in a given environment with a certain
reward schedule, the organisms should become less sensitive to feedback that does not support
what is learned. This and other predictions of the model were confirmed using a large set of
behavioral data in monkeys during a probabilistic reversal learning task [Farashahi et al., 2017].
Although the proposed metaplasticity mechanism enables the model to become more robust against
random fluctuations, it also causes the model to not respond quickly to actual changes in the
environment. This limitation can be partially mitigated by allowing synapses to become unstable in
response to changes in the environment [ligaya, 2016]. Interestingly, in our model, the changes in
the activity of neurons that encode reward values can be used by another system to compute
volatility in the environment. This signal can be used subsequently to increase the speed of learning
when volatility is high, that is, when there is a higher chance of real changes in the environment. We
hypothesize that such interactions between value-encoding and uncertainty-monitoring systems can
enhance adaptability required in dynamic environments.
In addition to this modeling study, we recently have shown that both basolateral amygdala
(BLA) and orbitofrontal cortex (OFC) have complementary roles in adaptive value learning under
uncertainty in rodents [Stolyarova & Izquierdo, 2017]. In this experiment, rats learned the variance in
delays for food rewards associated with different visual stimuli upon selecting between them. We
found that OFC is necessary to accurately learn such stimulus-outcome association (in terms of
1
21